GROWTH HORMONE AND PROLACTIN PROFILES IN ACROMEGALY DURING SANDOSTATIN THERAPY

This study is intended to determine the effect of the somatostatin analogue, Sandostatin, on growth hormone and prolactin secretion in patients with acromegaly.